Translational Control of Megakaryocyte and Platelet Gene Expression in Disease

Overall Summary/Abstract
This Outstanding Investigator Award R35 program addresses previously-unexplored mechanisms by which
regulation of gene expression at the translational level controls the functions of megakaryocytes and platelets,
in the setting of health and disease. Studies will employ basic and clinical investigations in humans and mice to
comprehensively determine how translational pathways that converge on Eukaryotic Initiation Factor 4E
(eIF4E) regulate megakaryocyte and platelet biology. Roles for translational control pathways in
megakaryocytes have not previously been studied, their functional significance in circulating platelets is
uncertain, and it is unknown how disease situations alter translational responses of megakaryocytes and
platelets. Thus, successful completion of the research objectives will fill key gaps in knowledge that need to be
addressed in heart, lung, and blood research. Results generated will also determine if translational control
pathway inhibitors, which are currently being tested in the clinic, have off-target effects on megakaryocytes and
platelets.

Public health relevance
Narrative This Outstanding Investigator Award R35 program will determine how cells that regulate blood clotting contribute to diseases of the heart, lung, and blood. Results generated my lead to new diagnostics and/or therapies for patients who suffer from heart attacks, sepsis, or blood disorders.